Exploiting new drug targets in extremely resistant M.abscessus by using small molecule Lipid II binders

Abstract
The public is increasingly at risk to emerging infectious diseases. The prevalence of resistant bacterial
pathogens is rendering current antibiotics ineffective, and making it essential that new drugs be
developed to fight infections caused by these agents. Lipid II is an essential precursor in bacterial
membrane biogenesis and an established, yet underutilized target for antibiotics currently in clinical
use. We have for the first time identified small molecule Lipid II binders, based on the interaction
between defensins, a family of natural antimicrobial peptides and Lipid II. Characterization of
promising Lipid II binders reveals that it uniquely binds to Lipid II and has potent activty against
Mycobacteria. This proposal aims to validate and optimize synthetic Lipid II binders as a novel class
of antibiotic compounds to combat pathogenic infections caused by these hard-to-treat bacteria.

Public health relevance
An increasing number of people are at risk for bacterial infections that cannot be effectively treated. Of particular concern is the rise in hospital-acquired infections. Infections caused by drug-resistant bacteria such as Mycobacterium abcessus are the cause of many fatalities and puts a burden on health care systems in many countries. This project aims to develop antibiotic agents to fight against these bacterial infections.